Harnessing Small Molecules to Probe the Structure and Function of Long Noncoding RNAs

Harnessing Small Molecules to Probe the Structure and Function of Long Noncoding RNAs: Equipment Supplement ABSTRACT The long-term goal of the PI is to develop highly specific, RNA-targeted, small molecule ligands to probe the dynamic structure, fundamental biology, and therapeutic potential of long noncoding RNAs (lncRNAs). Despite the proposed therapeutic potential of lncRNAs, adequate small molecule targeting strategies have yet to be realized. This slow progress is due in part to a gap in knowledge with respect to guiding principles and methods for small molecule:RNA interactions. Our central hypothesis is that the parallel discovery of small molecule chemical space and RNA topological space privileged for differentiation will yield fundamental insights into small molecule:RNA recognition that can be applied to the rapid development of ligands with high affinity and specificity for a wide range of RNA targets. In the proposed work, we simultaneously pursue two independent but complementary lines of fundamental investigation and apply the developed guiding principles and technologies to two critical lncRNA targets. In Area 1, we use cheminformatic analysis, organic synthesis, and rapid screening methods to identify small molecule properties biased toward specific RNA recognition. In Area 2, we use pattern recognition protocols to identify RNA structures that are readily differentiated by small molecules. In Area 3, we combine our RNA-biased libraries and optimized screening assays to identify the first inhibitors of lncRNA tertiary structure, particularly the 3?-triple helix of MALAT1. In Area 4, we use a wide range of computational and experimental tools to identify small molecules that inhibit lncRNA:protein interactions, viz. HOTAIR and its protein binding partner, PRC2. The rationale for this research is that our novel RNA-specific libraries and technologies will enable new investigations of RNA structure and function and serve as a rich platform for future development of RNA targeted therapeutics. We are requesting an automated liquid dispenser, specifically the Multidrop Combi nL Reagent Dispenser (Thermo Scientific), which will exponentially increase our ability to generate the necessary data to achieve these goals.

Public health relevance
PROJECT NARRATIVE RNA is involved in nearly all biological processes, including several that are critical to the progression of human diseases, but we currently have few tools to study and control RNA function. The proposed research will develop a diverse but uniquely RNA-targeted small molecule library along with effective general strategies for the targeting of disease-related RNA structures. These studies are expected to increase understanding and ultimately treatment for a range of critically important targets in human health, including resistant bacterial infections, HIV viral infections, neuromuscular diseases, and metastatic cancer.